Unravelling the Role of Epigenetics and Cytokines in Type 2 Diabetes among African-ancestry Populations

PROJECT SUMMARY/ABSTRACT
African-ancestry populations in the US and Europe are disproportionally affected by type 2 diabetes (T2D), while rates are
rapidly increasing in sub-Saharan Africa. The reasons for this disproportionate burden are poorly understood but thought
to be a complex interplay between genetic and environmental factors, such as lifestyle. Previous work led by the candidate
demonstrated that T2D in Africans can partly be traced back to DNA methylation – an important epigenetic mechanism
that is a key mediator in the interplay between genetics and lifestyle factors. The candidate’s ongoing work suggests that
variations in circulating cytokines, partly driven by African-ancestry specific genetic variants, may play a role in the biology
of T2D in Africans. To improve our understanding of the etiology of T2D in Africans, it is imperative to establish causality
in previously observed associations and to identify regulatory mechanisms by which these factors are related to T2D. To
achieve this, the candidate will leverage data from three existing cohorts: sub-Saharan Africans living in Africa from the
AADM study, sub-Saharan Africans living in Africa and Europe from the RODAM study, and African Americans in the US
from the HUFS study. To test the hypothesis that changes in circulating cytokines induced by lifestyle factors increase T2D
risk through epigenetic mechanisms, the candidate will accomplish three specific aims. To achieve Aim 1, the candidate
will assess the causality in the previously observed association between DNA methylation and T2D in Africans by means
of two-sample Mendelian randomization (MR) approaches. Aim 2 is to determine whether cytokines act as a causal
mediator between lifestyle factors and T2D. This will be achieved in two steps: For the first step (Aim 2a), the candidate
will use multiple polygenic prediction methods to compute risk scores, such as polygenic risk scores (PRS), for a set of 12
diabetes-related cytokines measured in AADM and HUFS. These risk scores will be used as instrumental variables in MR
analysis. For the second step (Aim 2b), risk scores for alcohol consumption, smoking, and BMI will be computed to infer
causality in lifestyle-cytokine associations. Lastly, Aim 3 will identify regulatory mechanisms by which cytokines relate to
T2D by using multi-omics data. Carrying forward relevant loci identified in the candidate’s recent research on the 12
cytokines of interest, mechanisms by which these loci exert their effect will be studied using genotype, whole genome
sequence, DNA methylation, and RNA-seq data. The candidate and primary mentor have established an excellent
mentoring committee to train the candidate in causal inference methods, including the application of MR approaches to
epigenetic data, polygenic prediction, and mediation analysis, as well as in multi-omics analysis. The Center for Research
on Genomics and Global Health (CRGGH) at the National Human Genome Research Institute (NHGRI) is world-renowned
for genetics and genomics research in diverse populations, and in African-ancestry populations in particular. It is therefore
the ideal environment for the candidate to receive training during the K99 phase of the project. The proposed training will
complement the candidate’s background in epidemiology and experience with epigenetics analysis and will allow the
candidate to develop into an independent investigator and leading expert in the field of cardiometabolic diseases among
African-ancestry populations.

Public health relevance
PROJECT NARRATIVE African Americans and African migrants in Europe are more likely to have type 2 diabetes compared to their European ancestry compatriots and the rates of diabetes in Africa are rising rapidly. The candidate proposes to apply novel genetic epidemiological approaches to large datasets of African Americans and sub-Saharan Africans to provide evidence regarding the role of epigenetics and circulating cytokines in type 2 diabetes. Improved understanding of the mechanisms underlying type 2 diabetes in Africans is imperative to guide both prevention and treatment efforts that promote ethnic health equity.